Molecular effects of cannabinoids on the Blood Brain Barrier in HIV-infected brain

Molecular effects of cannabinoids on the Blood Brain Barrier in HIV-infected brain
Infection with the human immunodeficiency virus (HIV) causes significant disease morbidity in the brain,
largely due to HIV-associated blood-brain barrier (BBB) disruption, inflammation, and persistence of HIV-infected
CNS target cells such as microglia and macrophages, in spite of antiretroviral therapies (ART). Cannabis is a
commonly used drug by people with HIV (PWH). Recently, we made the important observation that the impact
of cannabis on BBB integrity markers is context-dependent, with signs of BBB disruption in non-HIV subjects,
but paradoxically improving BBB integrity in PWH. This observation makes it a high priority to understand the
mechanistic basis of this dichotamous influence of cannabis on the BBB. Cannabis and HIV interact in
multifactorial ways that are still poorly understood. Importantly, HIV brain target cells microglia/macrophages
express the cannabinoid receptor 2 (CB2R), while endothelial cells of the blood brain barrier (BBB) express both
CB1R and CB2R and other cannabinoid receptors such as GPR55. It is also unknown how cannabis influences
HIV-associated brain inflammation or the active/latent status of HIV in infected microglia. By protecting vascular
integrity, it follows that cannabis will not only affect the select transport of substrates into the CNS, it will also
directly influence the infiltration of inflammatory cells and the passage of ART or other treatments to the brain.
The goal of this application is to test the hypothesis that cannabinoids positively impact BBB integrity in
the HIV-infected brain environment, leading to reduced inflammatory cell infiltration and ultimately
protection from HIV-associated neurocognitive disorders. Our analysis of two human brain microvascular
endothelial cell (HBMEC) lines (hCMEC/D3 and HBMEC/ci18) with opposing vascular integrity responses to
cannabinoids in the context of HIV suggest a molecular mechanism that can explain the context-dependent
effects of cannabis in human BBB properties. Based on this preliminary data, our hypothesis posits that beneficial
effects of cannabinoids in the context of HIV occur via CB2R, while cannabinoid signaling via GPR55 may be
damaging. In the proposed studies we will model the human BBB in vitro using multicellular systems containing
the two HBMEC lines in parallel, along with pericytes, astrocytes and microglia, to replicate HIV-induced vascular
phenotypes characterized by loss of tight junction proteins and increased permeability to fluorescent labelled-
dextran. Implications to infection in the brain will be validated in vivo using the EcoHIV mouse model, which
develops BBB disorders. Successful completion of these experiments will define the molecular mechanisms that
underlie the dichotomous influence of cannabis on the BBB in the context of HIV, forming the basis of new
approaches aimed at optimizing BBB integrity.

Public health relevance
Molecular effects of cannabinoids on the Blood Brain Barrier in HIV-infected brain The HIV infection causes significant disease morbidity in the brain, largely associated to blood-brain barrier (BBB) disruption, inflammation, and persistence of HIV-infected CNS target cells such as long-living microglia, in spite of antiretroviral therapies (ART). We found that cannabis use modulate the expression of BBB integrity markers in a context-dependent manner, increasing signs of BBB disruption in non-HIV subjects, but paradoxically improving BBB integrity in PWH. This observation motivated an in-depth examination of how cannabinoids impact BBB integrity, with consequences to inflammatory cell transmigration and protections against HIV-infection in the brain, by modeling the human BBB in vitro and in vivo systematically testing critical determinants, cellular interactions and targets, which can be used to inform mechanisms and new approaches aimed at optimizing BBB integrity in the context of HIV.